Senior Leadership

PROJECT SUMMARY (See instructions): The Senior Leadership of the Kimmel Cancer Center (KCC) is responsible for the overall operation, management, and planning for the Cancer Center. This includes the administrative and management oversight of activities in support of research within the Center, including the research programs, shared resources, and clinical activities. The Senior Leadership includes: Director of the KCC ~ Richard G. Pestell, M.D., Ph.D., MBA Deputy Director for Basic Science -Erik Knudsen, Ph.D. Deputy Director for Clinical Science ? Neal Flomenberg, M.D. Co-Deputy Director for Basic Science -Timothy Block, Ph.D. Associate Director for Translational Research -Wm. Kevin Kelly, D.O. Associate Director for Education ~ Marja Nevalainen, M.D., Ph.D. Associate Director for Clinical Investigations ~ Matthew Carabasi, M.D. Associate Director for Clinical Affairs ~ Leonard Gomella, M.D. Associate Director for Shared Resources - Richard L. Davidson, Ph.D. Associate Director for Diversity Affairs - Edith Mitchell, M.D. Associate Director for Population Science - Ronald Myers, Ph.D. Chief Financial Officer ~ Richard Haldeman, MBA, CPA

Public health relevance
RELEVANCE (See instructions): The senior leadership of the KCC is comprised of a diverse set of basic and clinical scientists who provide leadership to the Cancer Center.